Differentiating clinical characteristics between two subtypes of antiphosphatidylethanolamine

ABSTRACT
Antiphosphatidylethanolamine (aPE) autoantibodies are associated with clinical symptoms of antiphospholipid
syndrome (APS). However, the clinical significance of aPE remains to be fully established. In an effort to define
aPE, we discovered that aPE actually consists of two distinctive subtypes. This notion is based on our findings
that there are two types of aPE antibodies – cofactor-independent (aPEi) and cofactor-dependent (aPEd), which
have different antigens and pathogenic mechanisms. In the current effort, we will investigate the clinical
characteristics of aPE subtypes in a retrospective study by testing the hypothesis that aPEi and aPEd antibodies
have different associations with the clinical and laboratory criteria for APS. The new knowledge will help define
and differentiate the two subtypes of aPE, with potentially important implications on diagnosis and patient care.

Public health relevance
NARRATIVE Emerging evidence indicates that anti-phosphatidylethanolamine (aPE) consists of two types of fundamentally different antibodies. We will investigate the clinical characteristics of the two aPE subtypes in a retrospective study. The findings will help define the clinical significance of aPE with transformative impact on diagnoses and patient care.